Trans/Forming Genomics: Guidance for Research Involving Transgender and Gender Diverse People

PROJECT SUMMARY
Transgender and gender diverse (TGD) people—individuals whose gender identity differs from the sex they
were assigned at birth—comprise approximately 1.6% of U.S. adults. Gender identity represents one’s concept
of self and can be the same as one’s sex assigned at birth (cisgender), different from one’s sex assigned at
birth (transgender), or beyond traditional classifications (non-binary, gender fluid, gender diverse). TGD
populations are disproportionately burdened by physical and mental health inequities and are a designated
NIH health disparities population. The recent explosion of biobanking, and more routine collection of gender
identity data and affords an opportunity to study possible genomic associations with gender identity. Such
research could affirm gender identity, or be used to pathologize and discriminate, limit access to care, or
influence the use of reproductive technologies. We aim to guide the field in order to maximize benefit and
minimize harm of such studies and meet a time sensitive need to inform how genomic data are collected,
analyzed, and reported to benefit diverse TGD populations and to advance scientific understanding. Research
on genomics and gender identity should be conducted with, and not on TGD communities to ensure that we do
not repeat past wrongs, for example excluding racial/ethnic populations from the conduct and reporting of
research that impacts these populations and further reifying stereotypes and stigma. In partnership with and
guided by a racially, ethnically, professionally and geographically diverse Executive Stakeholder Board and
workgroups consisting of TGD community members, advocates, clinicians, and ethics, legal, and genomics
and health equity scholars, we will explore perspectives on the potential risks and benefits of studying genomic
associations with gender identity. Together we will: 1) assess gaps in the literature and define ELSI themes for
further exploration and inclusion in the Guidelines; 2) conduct a sequential mixed-methods study comprised of
in-depth qualitative interviews with TGD community members (N=40); quantitative surveys with TGD
community members (N=400); and listening sessions with key stakeholders (genomics researchers, TGD-
serving clinicians, ethical and legal scholars, institutional review board members) (N=32); and 3) convene a
larger Summit to develop the Guidelines. We will use a formal process of deliberative engagement led by a
facilitator with experience in facilitated dialogue in TGD communities to identify priorities, resolve conflicts,
make decisions, develop guidelines and recommendations, and widely disseminate these to policy, research
and TGD communities This project will address aspects of all four NHGRI/ELSI priority research areas. Our
work will result in standards and best practices to guide genomic research about gender identity. Our Board,
Workgroups and Summit participants will function as a national network to provide ongoing consultation,
guidance, and leadership on genomics research with TGD populations.

Public health relevance
PROJECT NARRATIVE The recent explosion in biobanking, more routine collection of data on gender identity, and rapid expansion of research in transgender and gender diverse (TGD) populations has afforded both an opportunity to study whether gender identity has genetic underpinnings, and a time sensitive need to inform how such research is used to benefit and not harm TGD populations. In partnership with and guided by an Executive Stakeholder Board of diverse TGD community members, advocates, clinicians, and ethics, legal, and genomics and health equity scholars, we will explore potential risks and benefits of studying genomic associations with gender identity, host a summit to develop guidelines and recommendations for such research, and widely disseminate our findings. Our team will continue to serve as a national network to provide consultation and leadership in the expanding field of genomic research related to gender diverse populations.